SEX STEROIDS IN AGE RELATED BONE LOSS

This study is designed to test whether serum sex steroid concentrations determine rates of bone loss around the menopause, whether serum sex steroid concentrations are associated with distinctive biochemical markers of rates of bone remodelling, and whether there are measureable declines in serum sex steroid concentrations associated with bone loss in premenopausal women.